Synthetic strategies for non-canonical hybridization to structural motifs in RNA

PROJECT SUMMARY/ABSTRACT
We propose herein a methodology to identify synthetic peptide-based binders to non-canonical structural
motifs in RNA. Reagents that selectively target these biologically important motifs would be transformative
theranostic tools for study and modulation of RNA-governed biology. The long-term goal of our research
program is to develop sequence and context-selective reagents for targeting of any such non-canonical
structural motif in lncRNAs. The objective of this application is to synthesize a small library of peptide-derived
reagents and quantitatively rank their competence in non-canonical hybridization to defined RNA structures,
using novel and robust functional screening methods in vitro and in cell culture. In contrast to the striking
progress of synthetic biology at the coding interface, non-canonical targeting remains in development. We
hypothesize that progress in this area is limited in a number of ways: 1) a prior focus on targeting Watson-Crick
(WC) paired bases rather than non-canonical pairs; 2) an over-emphasis on intercalation-driven binding; 3)
lack of exploration of secondary structure in RNA targeting reagents; 4) lack of a unified functional assay to
rigorously evaluate binding. We further hypothesize that synthetic binding solutions exist for every
non-canonical motif; if these solutions could be found, then non-canonical hybridization could be programmed
in the same way that duplex hybridization is programmed. Such an advance would enable precise interrogation
of nucleic acid biology with novel chemical tools. The rigor of the prior research lies in the known efficiency of
synthetic bases in targeting select non-canonical pairs, as well as preliminary data demonstrating tunable and
expansive binding selectivity via backbone and base modification. We will test our central hypothesis and
accomplish the overall objective of this application via the following three specific aims: 1) Synthesis and
evaluation of bPNAs targeting non-canonical sites via base-triple formation; 2) Enzymatic and functional
assays for bPNA-RNA targeting efficacy; 3) In vitro and intracellular bPNA targeting and selectivity for
structural motifs in native RNAs.

Public health relevance
PROJECT NARRATIVE Greater inhibitory precision would lead to reduced side effects in therapeutics and deeper biological insight. The proposed research is significant because it will contribute a set of transformative theranostic tools for study and modulation of RNA-governed biology through inhibition and reporting of critical RNA tertiary interactions. If successful, our approach would open new potential therapeutic and diagnostic avenues via probing and inhibition of RNA tertiary contacts.